Aging Symptom Trajectories in Mother Carriers of the FMR1 Premutation

PROJECT SUMMARY/ABSTRACT
About 1 in 151 women in the US are carriers of a genetic abnormality called the FMR1 premutation
(FXpm). Mothers who carry the FXpm are at risk for passing the mutated gene to their children, which may result
in fragile X syndrome. The FXpm is also associated with substantially increased risk for disease, including
neurodegenerative disease, premature menopause, psychiatric involvement, and executive and social deficits.
The parent R01 seeks to determine the stability of key FXpm phenotypes (mental health, executive, social)
across midlife and early old age in FXpm carrier mothers compared to healthy controls (Aim 1); investigate
autonomic and molecular-genetic factors associated with age-related symptom expression and their interface
with parenting stress (Aim 2); and evaluate functional limitations associated with FXpm symptoms across age
(Aim 3). We will accomplish these aims by adopting an accelerated longitudinal design to track age-related
change occurring across 45-80 years in 75 FXpm carrier mothers compared to 75 control mothers. The over-
arching goal is to inform the critical age periods and risk factors in age-related decline, as well as to lay the
groundwork for future mechanistic studies. This work is necessary to develop strategies to ameliorate FXpm
symptoms, which will improve outcomes for both FXpm carrier mothers and their children with fragile X
syndrome.
This diversity supplement application will support Ms. Ariyo, a promising high school scholar, to obtain
meaningful experience in health-related research to stimulate interest in research careers in science.

Public health relevance
PROJECT NARRATIVE The parent R01 aims to define age-related stability of symptoms experienced by mothers with the FMR1 premutation in midlife and early old age and associated functional limitations. This diversity supplement application will support Ms. Ariyo, a promising high school scholar, to obtain meaningful experience in health- related research to stimulate interest in research careers in science.